IMMUNOTOXIN TREATED HELA SPHEROIDS EXAMINED THROUGH CONFOCAL MICROSCOPY

We propose to use confocal microscopy to examine the effect of immunotoxin treatment on HeLa spheroids. This involves two main sets of experiments: the first would measure the distribution of fluorescently-labeled immunotoxin in spheroids, and the second would examine immunotoxin-induced cytotoxicity as a function of position in the spheroid using a live/dead staining system and/or a probe for metabolic activity such as Rhodamine 123. The results of these experiments would then be used to confine or modify a mathematical model which describes immunotoxin penetration into spheroids and relates it to cytotoxicity.